LINKAGE ANALYSIS OF NON SYNDROMIC CLEFT LIP W/ OR W/OUT CLEFT PALATE

Actinic prurigo is an idiopathic photodermatosis seen in American Indians; the face and other sun-exposed areas are usually involved, the patients being sensitive to ultraviolet A light. A modified dominant form of inheritance has been proposed for the disease, but formal segregation analysis has never been performed. Large pedigrees of Cree Indians and M[unreadable]tis (mixed American Indian and white) of Cree ancestry have been ascertained in which the disease appears to be segregating and detailed data on relationships and age of onset are being collected. Data collection is now complete and segregation analysis is being performed to confirm or refute a single gene mode of inheritance.[unreadable]